Targeting the orexin pathway to treat sleep disorders and improve glymphatic clearance in Alzheimer’s disease

PROJECT SUMMARY/ABSTRACT FOR FUNDED GRANT
Note, this is a redundant copy required by our submission system, the abstract is also
included within the 5 page Research strategy as requested in the application
instructions.
Alzheimer’s disease is devastating for individuals and society. Impaired learning and memory,
particularly in the context of spatial navigation, is one of its early and major symptoms. Similarly,
rodents recapitulating aspects of Alzheimer’s disease also exhibit early impairments in spatial
navigation. A preponderance of evidence suggests abnormal cortical-hippocampal
communication in humans with Alzheimer’s disease. Hippocampal-cortical interactions during sleep
are thought to be critical for consolidation of newly acquired memories. However, no studies have
assessed these brain dynamics during sleep in rodents modeling Tau and amyloid beta
(Aβ) aggregation aspects of Alzheimer’s disease. Thus, the proposed research will explore the
functionality of brain dynamics during sleep in the hippocampal-PC network in animal models of
Tau and Aβ aggregation (TAβA). To do this, we will use a triple transgenic mouse where three
major genes associated with familial Alzheimer’s disease are expressed leading to TAβA. This
mouse model mimics plaque and tangle pathological hallmarks of the disease, with a distribution
pattern similar to human patients, including synaptic changes in the limbic system. In addition, all
findings will be confirmed in a transgenic rat with Aβ accumulation, plaque formation, tau
accumulation, cell loss, and spatial memory impairments. Specifically, we will: 1) assess the
relationship between spatial learning and memory, as well as brain dynamics during sleep, both
within and across the hippocampus and cortex; 2) use a novel targeted optogenetic approach
to functionally dissect the relative contributions of TAβA in the hippocampus to impaired
hippocampal-cortical coupling during sleep and impaired spatial learning. 3) test the efficacy of
a non-invasive visual stimulation approach, known for clearing cortical TAβA, to relieve
impaired hippocampal-cortical coupling during sleep and impaired spatial learning. This project
will provide insight into the normal function of a circuit that is dysfunctional in Alzheimer’s disease
and allow us to probe dysfunction in this circuit that emerges in very early stages of disease
progression in rodents modeling TAβA aspects of Alzheimer’s disease. This research will allow
us to begin understanding changes in this network which may underlie the emergence of cognitive
impairments observed in Alzheimer’s disease and begin testing the efficacy of a non-invasive
treatment for reversing the functional brain abnormalities and impaired cognition.

Public health relevance
PROJECT NARRATIVE The focus of this research is on the sleep related function of a brain network that is affected by Tau and amyloid beta deposition in Alzheimer’s disease and the relationship between these functional changes and impaired memory in Alzheimer’s disease. This research is relevant to public health because it will increase knowledge about the role of changes in the functional interactions between the cortex and hippocampus and use current technologies to perform a functional dissection of Tau and amyloid beta clearance in these critical brain circuits, including a noninvasive approach for clearing tau and amyloid beta. The proposal is relevant to NIH’s mission in that it will expand the knowledge base, and establish a new research platform for understanding the mechanism of impaired memory in Alzheimer’s disease.